Does suppression of glymphatic flow explain why chronic neuropathic pain elevates the risk of developing Alzheimer-like dementia?

The goal of this application for an administrative supplement for R01AT011439 is to expand ongoing studies of
chronic neuropathic pain to include a murine model of Alzheimer’s disease (AD). It is known that more than 50%
of patients with AD suffer from either acute or chronic pain. Pain in patients with AD is often unrecognized or
undertreated, and current medical treatment can have considerable side-effects in dementia patients including
adverse drug–drug interactions. Thus, an even greater need exists for identifying non-pharmacological
approaches to reduce pain in patients suffering from Alzheimer disease than in the remaining population.
Our underlying hypothesis is that the glymphatic system – a brain fluid transport system - sits at the crossroad
of physiological and maladaptive responses to chronic neuropathic pain. We proposed that many of the classical
presentations of chronic neuropathic pain are a consequence of glymphatic malfunction, including cytokine
accumulation, neuronal hyperexcitability, and poor sleep quality. We are now proposing to expand the ongoing
studies to include a murine model of Alzheimer disease: the APP/PSI mouse line. The proposed studies will test
the hypothesis that pain induced by spared nerve injury (SNI) is more severe in the APP/PS1 mice than in age-
matched controls because the glymphatic system is already suppressed. We will also test the corollary
hypothesis that chronic neuropathic pain potently accelerates the loss of cognitive function and amyloid-
aggregation due to the reduction of glymphatic clearance in APP/PS1 mice. We propose to systematically map
the time course of chronic neuropathic pain in APP/PS1 mice and compare to age-matched controls in 4-, 8-,
and 18-months old mice. We will test the following questions:
Aim 1. Does suppression of glymphatic flow explain why chronic neuropathic pain elevates the risk of
developing dementia? These experiments will correlate glymphatic clearance with both the severity of pain and
severity of AD (cognitive test and amyloid- deposition) in 4-, 8-, and 18-month old mice APP/PS1 mice, age-
matched littermate controls, and wildtype C57BL/6J mice.
Aim 2. We propose that complementary interventions including omega-3 fatty acid supplementation,
exercise, and improved sleep (induced by elevating temperature in the light phase) will lower baseline
NE levels and improve both sleep architecture and glymphatic flow. The key endpoint of Aim 2 is to test
whether the interventions preserve cognitive function in APP/PS1 mice and slow amyloid- aggregation.
By collecting a large set of behavioral, physiological, and histological data in individual mice, including cytokine
profile, sleep architecture, and norepinephrine levels, we will use correlation analyses will test the hypothesis
that glymphatic clearance failure after SNI is the missing link explaining why neuropathic pain accelerates the
progression of AD.

Public health relevance
The “glymphatic system” is a network of perivascular spaces that function as a waste clearance system, analogous to the peripheral lymphatic system. Reduced glymphatic function has been a hallmark observation in models of Alzheimer’s disease and in chronic neuropathic pain. This application aims to define whether chronic neuropathic pain suppresses glymphatic clearance and accelerates cognitive decline and protein aggregation in a murine model of Alzheimer disease. The proposed studies will also test the effect of omega-3 fatty acids, exercise and improved sleep quality as alternative interventions to reduce the severity of pain and slow Alzheimer disease progression.